De-implementation of low value castration for men with prostate cancer

Project Background: Prostate cancer is the leading male cancer. One in three men with prostate cancer is
chemically castrated at some point with long-acting injectable drugs (i.e., androgen deprivation therapy or
ADT). This impacts the well-being of thousands of men annually. Although some patients benefit in terms of
survival and symptom improvement, chemical castration with ADT is also commonly performed when there
are little to no health benefits to patients raising questions of low value care. A growing awareness of
castration harms (e.g., heart attack, osteoporosis, loss of sexual function) creates patient safety concerns.
Despite this, ADT use in low value cases, such as for localized prostate cancer treatment persists.
Ineffective and harmful practices such as chemical castration of prostate cancer patients with ADT outside
of the evidence base are ideal targets for de-implementation. De-implementation, or stopping low value
practices, has the potential to improve patient outcomes and decrease healthcare costs. However, provider
preferences regarding de-implementation are not well understood, and possible de-implementation
interventions range from blunt formulary restriction policies to shared decision-making. Both intervention
strategies need tailoring based on provider input for acceptability and feasibility in clinical practice, including
piloting prior to trialing. As many medical practices lack evidence and cause harm, robust, behavioral
theory-based methods for incorporating provider preferences into deimplementation strategy development
will advance both implementation research and practice.
Project Objectives: This study will use a theory-based, mixed methods approach to identify, tailor and pilot
two different de-implementation strategies that vary widely in delivery, impact, and expected results for
reducing low value ADT use, in preparation for a randomized comparative effectiveness trial.
Project Methods: This innovative mixed-methods research program has three aims. Aim 1: To assess
preferences and barriers for de-implementation of chemical castration in prostate cancer. Guided by the
Theoretical Domains Framework, urologists from facilities with the highest castration rates across an
integrated delivery system will be interviewed to identify key preferences and de-implementation barriers for
reducing castration as prostate cancer treatment. This qualitative work will inform Aim 2 while gathering rich
information for two proposed pilot intervention strategies. Aim 2: To use a discrete choice experiment, a
novel barrier prioritization approach, for de-implementation strategy tailoring. A national survey of urologists
will prioritize key barriers identified in Aim 1 for stopping castration as localized prostate cancer treatment
using a discrete choice experiment design. These quantitative results will identify the most important
barriers to be addressed through tailoring of two pilot de-implementation strategies in preparation for Aim 3
piloting. Aim 3: To pilot two tailored de-implementation strategies to reduce castration as localized prostate
cancer treatment. Building on findings from Aims 1 and 2, two de-implementation strategies will be piloted.
One strategy will focus on formulary restriction at the organizational level and the other on physician/patient
decision-making. Outcomes will include acceptability, feasibility, and scalability in preparation for an
effectiveness trial comparing these two widely varying de-implementation strategies. This innovative
approach to de-implementation strategy development will transform how and why castration is performed
for localized prostate cancer through combining provider preferences and strategy tailoring. This work will
advance de-implementation science for low value cancer care and foster participation in a subsequent de-
implementation evaluation trial by addressing preferences and concerns through pilot tailoring.

Public health relevance
Men with prostate cancer are often castrated with long-acting injectable drugs. Although many benefit, these drugs are also used in patients with little or nothing to gain. The best ways to stop this practice are unknown, and range from blunt pharmacy restrictions to shared decision-making. This study will refine and pilot two different de-implementation strategies for reducing use of these drugs among those unlikely to benefit in preparation for a comparative effectiveness trial. Due an aging population of men with prostate cancer, reducing castration in those least likely to benefit promotes quality care and quality of life. This study will transform how and why low value castration is practiced, and advance the science behind stopping low value, even harmful, cancer treatments.